Spatial characterization of microbial communities in the cystic fibrosis lung

Project Summary The human microbiome is gaining widespread attention for its link to host health and disease. This is particularly true of the cystic fibrosis airways, where a complex microbial community is recognized to be the major cause of patient mortality. In addition to Pseudomonas aeruginosa, a recent surge in culture- independent studies has generated a growing list of suspected pathogens and their correlation to disease progression. Yet, our inability to effectively treat these patients remains due to a lack of understanding of the CF lung environment and how specific chemical parameters define the presence or absence of a given bacterial species. In natural environments, such as a marine sediment, defining the effect of environmental chemistry on the microbial community is paramount in fully understanding a given ecosystem. Yet, this approach in a medical microbiology context is seldom used. Here, my overarching goal is to apply standard environmental microbiology principles and methodologies to test the hypothesis that the complex chemistry of the bronchial tree affects its resident microflora on multiple scales. Recently, we discovered a highly significant correlation between a class of microbially-produced metabolites (phenazines), microbiome composition, and lung function decline. In the K99 phase of this award, the overall goal will be to expand on these initial observations, and to broadly investigate the effect of the cystic fibrosis lung environment on its microbiome. Using a cohort of pediatric patients, I will first test that phenazines alter the redox state of iron, which ultimately correlates to a shift in the overall lung microbiome and disease progression. In addition, I will use novel imaging methods to investigate the cellular response of individual species (particularly P. aeruginosa) at the single cell level to changes in environmental chemistry (specifically in response to iron). These studies will reveal the potential of using single cell transcriptional activity as a direct readout of the ambient environment of the airways, and will potentially guide the design of novel therapeutics based on environmental chemistry. Next, we will apply these methods to explanted lung samples in order to better understand the spatial heterogeneity of microbial communities throughout the bronchial tree. With this information in hand, these studies will ultimately be expanded in the R00 phase of the award to include other metabolites and chemical parameters within the respiratory tract, and other sites of infection within the host. Altogether, this systems approach to understanding the ecology of microbial infections will change the way we think about the microbiome and its link to health and disease, and has the potential for development of novel therapeutic strategies.

Public health relevance
Project Narrative The aim of this study is to use ecological approaches to understand how microbial pathogens co-evolve with the chemical environment of the human body. There now exists a wealth of data on the human microbiome and its link to health and disease, yet the environmental parameters that define the presence or absence of specific members in a range of infectious contexts remain poorly understood. Understanding the mechanisms whereby pathogens invade and adapt to various host environments may reveal novel targets for antimicrobial therapeutics. __SpecificAimsTextDelimiter__ Specific Aims The human microbiome is gaining attention for its link to health and disease. This is particularly true of cystic fibrosis (CF) patients, where the primary cause of mortality is polymicrobial infection. Life expectancy continues to increase, though our lack of efficient therapies stems from not knowing how bacteria adapt to the complex chemistry of the airways. More specifically, little is known about how the lung environment determines the presence or absence of a given pathogen. Thus, understanding the effect of body environment on microbial composition might lead to novel therapeutic strategies. Here, the broad objective is to gauge the importance of microbial ecology in human disease. Beginning with CF, I will test the hypothesis that environmental change results in a microbiome shift, in turn affecting disease progression. Preliminary data suggests this is the case - phenazines (redox-active metabolites produced by P. aeruginosa) negatively correlate with CF microbiome complexity and pulmonary decline, yet the mechanisms by which phenazines shape the bacterial population remain unclear. Based on observations that phenazines promote Fe(III) reduction, they might help control the redox state of iron within the airways. In turn, subpopulations of the CF microbial community sensitive to iron chemistry could rise in prominence, leading to pulmonary decline. In these studies, I will use a multi-technique approach to test this hypothesis and begin to address the importance of microbial ecology in human health. Eventually, these findings will be extended to other sites of infection such that ecological interactions can be compared in many infectious contexts. To accomplish these goals, I propose three specific aims: Aim 1. Determine how the chemical environment of the CF lung correlates to its resident microflora. In collaboration with CHLA, I will test whether phenazines change iron speciation, resulting in shifts in the microbial composition of the lung. Sputum from a pediatric cohort will be collected and assayed for phenazine content and iron speciation. We will then compare these results to community sequencing data in order to generate models of microbiome response to environmental change. By stratifying data according to patient health, a greater understanding of how environmental chemistry might shape the human microbiome and host disease states will be achieved. Further, novel imaging methods will be applied to quantify Fe(II)-responsive gene expression in situ, in hopes of utilizing single cell activity as a direct readout of lung chemistry. The major part of Aim 1 will be accomplished during the K99 phase, and will help guide experiments proposed in Aim 2. Aim 2. Assess the spatial variation of microbial communities and their metabolisms throughout the bronchial tree. The spatial organization of microbial populations throughout the respiratory tract is not known. Environmental chemistry variation between upper and lower airways is appreciated, and likely has significant bearing on the microflora at these loci. Yet, most measurements of bacteria and their metabolic activities only provide an average readout once sputum is expectorated. To better understand spatial heterogeneity, we will acquire explanted lungs from patients in late stages of disease. Specimens will be dissected and examined to assess in situ spatial variation using the approach from Aim 1. Aim 2 will be performed during the K99 phase but will be advanced in the R00 portion once protocols are established and initial datasets are generated. Aim 3. Extend these findings to encompass other environmental parameters and sites of infection. An exciting aspect of Aims 1 and 2 is that phenazines and iron represent just two parameters that can shape the human microbiome. Going forward, it will be important to consider host genetics, diet, and other bacterial metabolites to reach a greater predictive understanding of microbiome dynamics. During the R00 phase, a broad assessment of additional environmental factors will be undertaken to build on ecological models of the CF bacterial community. In a greater context, chronic conditions that are associated with bacterial population shifts (such as obesity and periodontis) will also benefit from a broad application of the approach described here. Indeed, a rigorous characterization at the microscale of the places within the human body where microbial ecology is of importance to human health will be pursued in the R00 portion of this award. Collectively, these experiments will alter the way we think about microbial communities and their relationship to human health and disease. The continued identification and characterization of environmental parameters that define our microbiome might not only generate a greater understanding of disease etiology, but provide rapid and reliable measures for predicting poor clinical outcomes and identifying novel therapeutic strategies. The experiments described here are a pioneering step in this direction.